Role of Lipogenic Pathways in Intestinal Remodeling after Gastric Bypass Surgery

PROJECT SUMMARY
The rising incidence of type 2 diabetes (T2D) highlights a growing need to understand mechanisms
behind highly-effective therapies such as Roux-en-Y gastric bypass surgery (RYGB) in order to develop better,
more widely-applicable treatments. Adaptation in the jejunum (Roux limb) is a hypothesized contributor to
diabetes improvement after RYGB, and this is supported by our lab’s work demonstrating a relationship of
jejunal adaptation with both glycemic control and T2D remission in humans. Our long-term goal is to
understand how changes in GI anatomy effect the powerful, durable shift in energy homeostasis observed after
bariatric surgery. The overall objective of this application is to understand how changes in GI anatomy elicit the
powerful, durable shift in energy homeostasis observed after bariatric surgery. Our preliminary data
demonstrate segment-specific activation of LXR signaling in Roux limb of mice and humans after RYGB which
is lost in humans without T2D remission, as well as downregulation of PPARa signaling and enrichment of
lipids, especially plasma membrane lipids, in Roux limb. The central hypothesis is that that alteration in
intestinal epithelial lipid homeostasis, driven by LXR and PPARa signaling, is necessary for RL adaptation and
associated improvements in glucose homeostasis after RYGB. The rationale for this project is that de novo
lipogenesis could be a pathway for local intestinal glucose utilization, which is supported by our preliminary
data. These experiments will allow us to directly test the role for lipogenic pathways to contribute to intestinal
adaptation and metabolic homeostasis more broadly. The central hypothesis will be tested in two specific aims:
(1) to test the hypothesis that LXR- and PPARa- mediated lipogenesis drives RL adaptation and glucose
regulation in diet-induced obesity; and (2) To test the hypothesis that changes in lipogenesis drive intestinal
epithelial adaptation in a disease-relevant in vitro model system. We will use mouse models including our
murine model of bariatric surgery in Aim 1; Aim 2 will use a jejunal organoid model derived from human
patients with obesity, who are undergoing bariatric surgery. This project will shed light on the key intestinal
epithelial cells responsible for Roux limb adaptation and ultimately, potential drug targets that could mimic the
beneficial effects of RYGB.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on understanding mechanisms behind bariatric surgery, which is the most effective intervention able to elicit remission of obesity-related type 2 diabetes (T2D). Completion of this project will test the role of lipogenesis and related putative mechanistic targets to mediate metabolically-significant intestinal adaptation after gastric bypass surgery. This approach could lead to the future development of nonsurgical therapeutic strategies. Thus, the proposed research is relevant to the NIH’s mission to foster discovery which has the potential to improve human health.